Alcohol Research Center-Treatment and Implications -Targeting the Shared Substrates of Alcohol Misuse and Cognitive Impairment: Accelerated rTMS for Older Adults with Alcohol Use Disorder

SUMMARY/ABSTRACT
Alcohol misuse is a risk factor for early onset cognitive impairment, contributing to 10% of early onset dementia,
with risk corresponding to amount consumed. Epidemiological estimates indicate 10-24% of those with current
alcohol use disorder (AUD) meet criteria for dementia while 9-22% of those with dementia abuse alcohol.
Furthermore, AUD appears to increase vulnerability particularly in women with a near three-fold increased risk
of dementia. Furthermore, continued drinking risks worsening cognitive decline and dementia progression, while
worsening cognitive impairment contributes to drinking escalation. Notably, there exists no intervention targeting
the intersection of alcohol misuse and cognitive dysfunction in older adults.
It is unclear whether alcohol-related impairments and structural brain changes represent classical Alzheimer's
Disease and Related Dementias (ADRD) neurodegenerative patterns. Despite the unclear etiopathogenesis,
there is emerging evidence that repetitive transcranial magnetic stimulation (rTMS) to upregulate
executive/cognitive control circuitry can improve cognition in ADRD, and separately reduce heavy drinking in
AUD. Our long-term objective is to optimize rTMS for simultaneous mitigation of both drinking and cognitive
dysfunction in older adults towards breaking this cycle and thwarting progression to dementia.
We propose to build upon our Charleston Alcohol Research Center (P50AA010761) expertise and infrastructure
to expand recruitment to older adults (60-85 years) with AUD and cognitive impairment (DSM-5 Mild
Neurocognitive Disorder). Participants (N=30) will receive high-dose accelerated rTMS: a recent innovation that
reduces treatment burden, is FDA-approved for treatment of depression, and most importantly demonstrates
rapid symptom improvements. Participants will receive 10 sessions of intermittent theta burst rTMS (iTBS-rTMS)
to left dorsolateral prefrontal cortex (individualized to functional network connectivity) for 5 days/week for 1-week.
All will undergo clinical assessments and resting-state fMRI at pre-treatment, at 1-week post-treatment, and 4-
week follow up. We will use established primary outcomes for ADRD trials (ADCOMS; NIH Toolbox-Cognition
Battery, Fluid Composite) and primary outcomes for AUD trials (self-report drinking (timeline follow back) and
craving along with urine ethylglucorinide (ETG) and carbohydrate deficient transferrin (CDT) biomarkers). We
hypothesize that iTBS-rTMS will enhance cognitive performance in AUD+MCI, as indexed in improved fluid
cognition, as well as enhance frontal-parietal connectivity (Aim1) and that iTBS-rTMS will result in fewer heavy
drinking and more abstinence days, and lower craving, ETG and CDT as well as enhanced connectivity between
the frontal-parietal and reward networks (Aim 2). Findings will guide a follow-up double blind, randomized
controlled trial of rTMS for AUD and MCI with 1-year longitudinal follow up to assess durability of staving off
heaving drinking and cognitive decline.

Public health relevance
PROJECT NARRATIVE Alcohol misuse is a risk factor for cognitive impairment and dementia and continued drinking risks worsening cognitive decline and dementia progression, while worsening cognitive impairment contributes to drinking escalation. Toward breaking this cycle, the goal of this project is to advance non-invasive brain stimulation, specifically accelerated repetitive transcranial magnetic stimulation for targeting the shared neurocircuit substrates contributing to alcohol misuse and cognitive dysfunction in older adults.